Scientific Core

Scientific Core – Summary Abstract
The Scientific Core of our P50 Clinical Research Center builds on the long history of shared
infrastructure at the Eaton-Peabody Laboratories, and consists of three Research Cores led by
PI Liberman: 1) an Engineering Core to design, build, program and maintain data-acquisition
systems, custom acoustical devices, and stimulus generation systems, to provide a precision
machining service to build custom mechanical devices for a wide variety of research
applications, and to share these software and hardware advances with the greater scientific
community; 2) a Histology-Surgery Core to maintain and stock a shared wet-lab facility for
histological processing and shared animal-surgery facilities, along with controlled substance
licensure, to train new users on histological and surgical techniques and to continually enhance
the quality of histological preparation throughout the Center; and 3) an Imaging Core to maintain
and train users on the shared confocal and epifluoresence microscopes, and to support digital
image-acquisition and analysis, via commercial software packages or, when necessary, via
creation of custom software to allow further automation of morphometry and 3-D reconstruction
and rendering.
The communal nature of the Cores provide a number of significant benefits including: 1)
enhancing inter-group communication, 2) providing economy of scale, 3) eliminating duplication
of effort involved maintaining separate Investigator-based facilities, 4) helping investigators
incorporate new approaches into their repertoire, based on the sharing of technical expertise
across researchers and disciplines, and 5) allowing the creation of shared hardware and
software systems with capabilities far beyond that achievable by individual PIs working in
isolation.

Public health relevance
Scientific Core – Narrative Public Health Relevance Our P50 Clinical Research Center assembles a team of four clinician scientists and basic scientists to study the mechanisms underlying three of most vexing aspects of sensorineural hearing loss, i.e. problems understanding in a noisy environment, reduced tolerance for even moderate-level sounds, and the phantom sounds of tinnitus. The Scientific Core leverages the considerable additional expertise of the numerous other hearing and deafness researchers at the Eaton-Peabody Laboratories by tapping into the longstanding technical Research Cores of this group, that have long been sharing expertise and a technical support staff to push the collective research further and faster.